Randomized Trial of Sodium-glucose cotransporter-2 Inhibition(SGLT2i) in Heart Transplant Recipients

Project Summary/Abstract
Heart transplant (HTx) is an established therapy for advanced heart disease that restores quality of life
and improves survival. However, due to preexisting comorbidities combined with the
immunosuppressive therapies required after transplantation, HTx recipients remain at high risk for
kidney, cardiovascular (CV), and metabolic disease. Large randomized clinical trials have recently
shown that sodium-glucose cotransporter 2 inhibitors (SGLT2i) have potent kidney protective and CV
benefits in many populations of patients with chronic kidney disease (CKD), CV disease and/or
diabetes. SGLT2i have not been studied prospectively in HTx recipients, which represents a barrier to
their use in this population, yet we believe these patients may derive multiple benefits from SGLT2i
based on the mechanisms of action. We are proposing a multicenter randomized controlled trial of
empagliflozin 10mg daily versus placebo for one year in Veterans with HTx enrolled at all six VA HTx
national referral centers at Salt Lake City, Nashville, Richmond, Madison, Palo Alto and Houston.
Kidney dysfunction is highly prevalent after heart HTx and is associated with a significant increase in
mortality. Albuminuria is present in approximately 50% of Veterans after HTx, and estimated glomerular
filtration rate (eGFR) begins to decrease linearly starting at the time of transplant. SGLT2i have been
shown repeatedly to decrease albuminuria and slow the rate of eGFR decline. We hypothesize that
SGLT2i with empagliflozin will similarly improve albuminuria and eGFR slope in HTx recipients (Aim
1). We also hypothesize that treatment with empagliflozin in HTx recipients will be associated with
favorable safety and tolerability. SGLT2i are overall well-tolerated with rare serious adverse events but
transplant recipients have been excluded from clinical trials of SGLT2i. We will establish the safety and
tolerability of SGLT2i therapy in HTx recipients (Aim 2). SGLT2i additionally have pleiotropic effects
on metabolism, inflammation, vascular function and erythropoiesis. We will evaluate the effects of
empagliflozin on markers of cardiometabolic risk (hemoglobin A1c, inflammation, blood pressure, body
weight) in HTx recipients (Aim 3a). Anemia is also common after HTx and is associated with poor
outcomes. We hypothesize that empagliflozin will increase markers of erythropoiesis (hemoglobin,
hematocrit, erythropoietin) (Aim 3b). As a result of CV, metabolic and/or erythropoietic benefits, HTx
recipients may experience an improvement in functional status and/or health-related quality of life,
which we will evaluate with a six-minute walk test and health-related quality of life metrics (Aim 3c).

Public health relevance
Project Narrative Heart transplant (HTx) recipients are at high risk for chronic kidney disease (CKD), cardiovascular (CV) and metabolic disease. Sodium-glucose cotransporter 2 inhibitors (SGLT2i) significantly improve kidney and CV outcomes in multiple populations and may show similar benefits in HTx recipients. We propose a multicenter randomized controlled trial of SGLT2i with empagliflozin 10 mg daily versus placebo for one year in order to assess the kidney, CV, metabolic, erythropoietic and functional effects of SGLT2i. We hypothesize that empagliflozin will decrease albuminuria and estimated glomerular filtration rate decline and will positively affect metabolic and erythropoietic parameters, with an accompanied improvement in functional status and health-related quality of life. We will also establish the safety and tolerability of SGLT2i use in HTx recipients.